DREAM: Discovering cancer Risks from Environmental contaminants And Maternal/child health

Project Summary/Abstract
The UCSF Discovering cancer Risks from Environmental contaminants And Maternal/child health
(DREAM) cohort will enhance our understanding of how multiple exposures to environmental chemicals and
pollutants across a diverse population of pregnant women and their offspring are linked to cancer risks. We will
enroll and follow an economically, geographically, ethnically, and racially diverse participant pool of pregnant
women and their children in the San Francisco Bay Area and California’s Central Valley. Because pregnancy
induces multiple maternal hormonal and physiological changes that can increase cancer susceptibility to
environmental chemical exposures, we will focus on pregnancy as a period of particular vulnerability to toxic
agents. We will collect questionnaire data and biospecimen samples starting at the second trimester of
pregnancy up until the child reaches four years of age. We will also establish a Cohort Ambassador Program to
invite participants across our three sites to provide continuous feedback which we will integrate into our research
priorities. Our specific aims are designed to address the hypothesis that exposures to environmental chemicals
that disrupt endocrine and other systems during this important life phase predispose women and children to
cancer, as identified via intermediate cancer risk biomarkers. Our environmental exposures will focus on two
major components: Consumer product related chemicals (including per- and polyfluoroalkyl substances [PFAS],
phthalates and plasticizers, phenolic compounds, pesticides, and aromatic amines) measured via biomonitoring
and prioritized based on widespread public exposure; and environmental pollutants in air and water, evaluated
via geographic information system analyses of participants’ residential histories. Our outcomes will focus on
biomarkers of risk for future cancer incidence including: short-term outcomes focusing on associations with key
characteristics that are intermediate cancer risk biomarkers (immune response and chronic inflammation,
oxidative stress and DNA damage, hormone disruption/receptor mediated effects, and cell immortalization). For
longer term outcomes we will link cohort participants to California’s statewide population-based cancer registry,
hospital discharge data, vital records, and Medi-Cal files in later years of the project to identify diagnoses of
cancer and related conditions. Our multidisciplinary collaboration is built on our extensive knowledge and
experience conducting large-scale research on environmental exposures during pregnancy and environmental
risk factors for cancer. Our proposed cohort development and research plan will advance our understanding of
multiple pollutant exposures in a young geographically and demographically diverse cohort, thus substantially
advancing our knowledge on enhanced susceptibility to carcinogens linked to specific outcomes during these
critical and understudied periods, combined with a platform that will allow flexibility and future collaboration to
enhance our study as new science emerges.

Public health relevance
Project Narrative The UCSF Discovering cancer Risks from Environmental exposures And Maternal/child health (DREAM) cohort is designed to fill current gaps in knowledge about the role of environmental exposures in cancer etiology by engaging with a diverse population of pregnant women. Through focusing on this critical, but understudied window of exposure, our study will contribute to an enhanced understanding of the relationships between multiple exposures to environmental contaminants and intermediate cancer risk biomarkers. In the long term, results can support earlier identification of risk factors, allowing for more effective prevention of environmentally mediated cancers.